VA GENIUS: Growing Excellence in Next-generation Investigators Undertaking Translational Science

Project Background: In the United States, individuals who identify as racial/ethnic minorities, women,
LGBTQ+, disabled, Veterans, or from rural or generationally poor backgrounds are underrepresented among
translational scientists.4-7 Public Law 114-329, the American Innovation and Competitiveness Act of 2017,
charged the federal government with addressing this disparity: “Given the shifting demographic landscape, the
United States should encourage full participation of individuals from underrepresented populations in STEM
fields.”8 Disparities in scientific participation reflect structural barriers that undermine scientific integrity and the
overall knowledge base.9-11 As part of the VA Office of Research & Development’s effort to address disparities
in science training and careers, this application proposes the VA GENIUS (Growing Excellence in Next-
generation Investigators Undertaking translational Science) program. VA GENIUS is a collaboration between
two VHA Centers of Excellence, the VA Rocky Mountain Mental Illness Research Education and Clinical
Center (RM MIRECC) and the VA Eastern Colorado Geriatric Research, Education and Clinical Center (EC
GRECC), in partnership with the Colorado Clinical and Translational Sciences Institute (CCTSI).
Impact on Veteran Health Care: The National Institutes of Health documented that, “individuals…when
grouped in diverse combinations, increase workgroup/team innovation and creativity,” which leads to better
outcomes.21, p. 12240 In recognition of the growing body of evidence that diverse research teams produce better
science, researchers focused on studying conditions affecting Veterans’ health have called for the
diversification of the research workforce to advance equity in Veteran health care.22,23 Attention to population
specific issues in research and development of interventions tailored to be responsive to diverse identities can
reduce disparities, improve care, and enhance Veteran perceptions of the Veterans Health Administration.24,25
Project Objectives: The purpose of VA GENIUS is to provide mentorship and applied educational
opportunities in the translational sciences to undergraduates from historically excluded groups to prepare them
for VA research and clinical careers. Its specific aims are to 1) facilitate participants’ advanced training in the
translational sciences, 2) increase participants’ interest in translational science careers, and 3) encourage
participants to choose VA careers.
Project Methods: The RM MIRECC participated in the three-year pilot program of the diversity summer
research program (SRP). VA GENIUS builds on the lessons of the successful pilot SRP and expands the
educational and research opportunities via new partnerships with EC GRECC and CCTSI to create greater
impact. The VA GENIUS training curriculum uses a combination of foundational education techniques including
interactive didactic presentations, structured readings and webinars, and independent research projects,
combined with innovative experiential learning including hands-on activities and participation, professional
observation and networking, and multi-tiered mentoring. This approach to education on the translational
sciences will both provide interns generalizable skills for study and work in other scientific settings
(foundational knowledge) and challenge and expand understanding of their own interests and possible career
paths (innovative participation). Both foundational knowledge and innovative participation learning will be
structured along the translational science spectrum (TSS), as described by the National Center for Advancing
Translational Sciences (NCATS), from preclinical to public health science.12 At the center of TSS is stakeholder
engagement. VA GENIUS interns will receive training on stakeholder engagement in research and meet with
three Veteran boards engaged in research. To assess the impact of VA GENIUS, we have outlined key
formative, process and summative evaluation questions, the associated metrics and indicators of success, and
data collection methods/measures, including the timing or frequency of administration.

Public health relevance
VA GENIUS (Growing Excellence in Next-generation Investigators Undertaking translational Science) is a collaboration of two VA Centers of Excellence, the VA Rocky Mountain Mental Illness Research Education and Clinical Center (RM MIRECC) and the VA Eastern Colorado Geriatric Research, Education and Clinical Center (EC GRECC), in partnership with the Colorado Clinical and Translational Sciences Institute (CCTSI). Its purpose is to provide mentorship and applied educational opportunities in the translational sciences to undergraduate students from groups historically underrepresented in the sciences, in order to prepare them for VA research and clinical careers. Its goals are to facilitate advanced training in translational science, increase interest in translational science careers, and encourage participants to choose VA careers. VA GENIUS builds on the lessons of the successful pilot SRP, which RM MIRECC participated in, and expands the educational and research opportunities via new partnerships with EC GRECC and CCTSI to create greater impact.